Engineering Immunomodulatory Scaffolds for Dental Pulp Regeneration

PROJECT SUMMARY
This K01 award describes a 3-year training program to support Dr. Franca's transition to scientific
independence. Dr. Franca is a dentist-scientist, and her long-term goal is to lead a research program to (i)
develop immunomodulatory biomaterials for dental and craniofacial regeneration and (ii) to create tissue
chips to understand and treat oral diseases. The scientific goal of this K01 is to develop an
immunomodulatory scaffold for dental pulp regeneration. Despite undeniable progress to develop
regenerative strategies for the dental pulp, necrotic teeth present challenging conditions for regeneration.
Even after careful disinfection, a previously infected root canal's microenvironment has remnant
lipopolysaccharide (LPS) that activates immune cells into a pro-inflammatory state incompatible with tissue
regeneration. Recently, early events of the immune response were shown to highly influence tissue
engineering strategies' success. Especially, macrophage responses to biomaterials have been identified as
essential mediators of scaffold remodeling and promising targets for immune-mediated regenerative
strategies. These cells can respond to external stimuli by changing their phenotype from pro-inflammatory to
pro-regenerative, with many intermediate states, in a process known as M1/M2 polarization. These two states
are highly plastic, function synergistically, and can be modulated by the scaffold's properties. When a scaffold
for dental pulp regeneration is placed in contact with LPS-contaminated dentin, it can be expected that M1
activation will persist without providing the pro-regenerative environment necessary for tissue formation.
Small antibodies or nanobodies have been used to neutralize LPS in Gram-negative infections and target
pathogens in scarcely accessible tissue microenvironments. Unfortunately, this therapeutic tool has not been
used for dental regeneration purposes. Our overarching hypothesis is that an immunomodulatory scaffold
that neutralizes LPS and increases the M2/M1 ratio in the scaffold-tissue interface will provide a sustainable
pro-regenerative microenvironment more favorable to dental pulp tissue formation. Hence, our goal is to
engineer a novel nanobody-laden photocrosslinkable hydrogel with fine-tuned stiffness and the ability to
neutralize dentin LPS. This scaffold will enable controllable guidance of M1 macrophages activation,
minimizing their presence within the root canal so that incoming monocytes can polarize into M2 cells,
infiltrate the hydrogel, and secret an anti-inflammatory cytokine milieu to foster dental pulp tissue formation.
We propose the following aims: (Aim 1) to determine the effect of scaffold's stiffness on M1/M2 macrophage
polarization, (Aim 2) to neutralize dentin LPS and reduce M1 polarization, and (Aim 3) to evaluate the
nanobody-laden scaffold's immunomodulatory capacity in vivo. Successful completion of these aims will
generate data on the interplay between scaffold's properties and macrophage function, forming the basis for
an R01 submission and the development of additional novel immunomodulatory materials.

Public health relevance
PROJECT NARRATIVE Every year, millions of people in the U.S. need some sort of endodontic treatment due to dental pulp infection and necrosis. Regenerative strategies in infected teeth are unpredictable mostly because bacterial lipopolysaccharide (LPS) remain in the dentin and activate the immune system, hindering dental pulp regeneration. In this proposal, we aim to engineer a hydrogel that can neutralize LPS and control the function of a critical cell of the immune system, the macrophage, to modulate the scaffold's integration with the host tissue, promoting dental pulp tissue formation, and benefiting millions of patients.